Mentoring and Research in Patient-Oriented Cardiovascular Pharmacoepidemiology

SUMMARY
This application will provide the Principal Investigator, Dr. Pamela Lutsey, with protected time and other
support to 1) accelerate a successful record of mentoring junior clinical investigators and graduate students
engaged in cardiovascular disease (CVD) patient-oriented research (POR), 2) obtain additional training in
pharmacoepidemiology, -omics and mentoring best practices and 3) advance her ongoing CVD
pharmacoepidemiology research program. Pharmaceuticals play a crucial role in the prevention and treatment
of CVD and other conditions. To improve the effectiveness of pharmacologic interventions on CVD outcomes,
we need junior clinical investigators conducting POR who have rigorous training and mentorship in the areas
of pharmacoepidemiology, clinical epidemiology of CVD, translational research methods and the use of
complex data sources. An expert in these areas, the candidate, Dr. Lutsey, proposes to apply K24 funds
toward the mentorship of POR scholars at the University of Minnesota who are committed to a research
career that will reduce the burden of CVD in the population through building rigorous evidence regarding how
to optimize use of pharmaceuticals in order to prevent CVD in at-risk populations and reduce risk of
recurrence among individuals with CVD. Aim 1 involves conducting pharmacoepidemiology POR comparative
effectiveness research to prevent CVD in at-risk populations and improve the outcomes among CVD
survivors. State-of-the-art pharmacoepidemiologic techniques will be applied to large administrative data
sources, specifically MarketScan and the Medicare 20% sample. Aim 2 will harness rich data from deeply
phenotyped cohorts to understand behavioral characteristics that influence the effectiveness of medications,
and glean added understanding of the physiologic mechanisms through which pharmacotherapies act. These
analyses will use data from the Atherosclerosis Risk in Communities (ARIC) study and the Multi-Ethnic Study
of Atherosclerosis (MESA). Findings from the proposed Aims will advance understanding of the role of specific
pharmacologic treatment strategies on CVD risk, and have potential to directly impact clinical practice,
reinforcing or leading to reconsideration of existing clinical guidelines. This proposal is structured to allow
trainees the flexibility to pursue their own hypotheses, motivated by their clinical experiences and interests.
With support from this K24, Dr. Lutsey plans to expand the breadth of her POR research activities, recruit new
junior clinical scholars into POR, and prepare them to make major scientific advances and launch their own
independent research careers.

Public health relevance
NARRATIVE Pharmaceuticals play a crucial role in the prevention and treatment of cardiovascular disease and other conditions. Additional research is needed to optimize their effectiveness. This K24 award would serve as a platform for the PI to grow her research program in cardiovascular pharmacoepidemiology patient oriented research, participate in career development activities to advance her methodologic knowledge, and spark opportunities for junior clinical investigators to lead clinically meaningful manuscripts while learning state-of- the-art pharmacoepidemiology methods.